VA Summer Undergraduate Research Experience (VA-SURE)

The VA Ann Arbor Healthcare System (VAAAHS) will offer laboratory-based, hands-on research experiences for
undergraduate students that are interested in biomedical research, referred to as VA Summer Undergraduate
Research Experience (VA-SURE). Recruitment for the program will focus on local undergraduate institutions
where students of color and other disadvantaged backgrounds make up a significant percentage of enrolled
students as well as within the local Veteran community. We will take advantage of our pool of experienced
mentors conducting VA research to provide students with an engaging and rewarding experience. The long-
term goal of this program is to prepare students for graduate school and a future career in biomedical research.
We believe that access to our knowledgeable mentors and exposure to the research environment along with
weekly enrichment learning and growth opportunities will provide them with tools to be successful. Students will
receive instruction in experimental design, execution, and data interpretation. To further enhance the
experience, students will also be paired with a graduate student peer-mentors from the University of Michigan’s
Immunology Program, a PhD granting program. The short-term goals of our program are three-fold: 1) for
students to leave the program with increased confidence when speaking about science, 2) for students to have
a more comprehensive understanding of what a biomedical resarch career could look like, and 3) for students to
identify as a scientist. We expect that many of the relationships created between students and their mentors,
both faculty and graduate student, will extend past the summer program and that our mentors will be available
to provide future career guidance.

Public health relevance
The VA Ann Arbor Healthcare System (VAAAHS) will offer laboratory-based, hands-on research experiences for undergraduate students that are interested in biomedical research. The long-term goal of this program is to prepare students for graduate school and a future career in biomedical research. The experienced mentors at the VAAAHS have a reputation for conducting translational research on diseases that are relevant to Veterans. All mentors participating in this program are funded VA Investigators conducting projects that are relevant to Veteran health, including but not limited to lung cancer, lung disease, infectious disease, hearing loss and vestibular dysfunction, and vascular disease. To further enhance the experience, students will also be paired with a graduate student peer-mentors from the University of Michigan’s Immunology Program.